Functionally Assessing Transcriptional Enhancers In Vivo

PROJECT SUMMARY
Hundreds of thousands of distant-acting enhancers control the function of the human genome by orchestrating
the transcription of genes during pre- and postnatal development and in normal and disease states of cells and
tissues. They display remarkable cell type specificity and dynamic spatial and temporal activity patterns. While
there is now abundant indirect evidence that sequence changes in enhancers are likely to impact substantially
on human phenotypic variation and many disease processes, our understanding of how biological function is
encoded within enhancer sequences remains incomplete. This represents a major challenge for the
interpretation of variation in enhancer sequences observed by whole-genome sequencing (WGS) in patients and
for linking sequence variants within enhancers to diseases and other phenotypes. Over the past 16 years, the
research program supported by this R01 has provided major insights into enhancer biology and groundbreaking
tools for enhancer discovery and characterization. This included the first demonstration of ChIP-seq from
mammalian tissues for enhancer discovery, and a constantly evolving suite of mouse engineering methods for
studying enhancers in vivo. This program has also produced the largest cohesive collection of human and mouse
in vivo-characterized enhancers available to date and provides the VISTA Enhancer Browser as a major
community resource. In the next phase of this research program, we propose to leverage the unique capabilities
previously developed under this program to further advance our understanding of general enhancer biology, to
complement the work of the recently established NHGRI Impact of Genomic Variation on Function (IGVF)
consortium with critically needed in vivo assessments of enhancer variants, and to provide enhancer resources
for the extended community. Our specific aims include: (1) We will explore the inner anatomy of enhancer
sequences through large-scale mutagenesis coupled to in vivo mouse assays. We will also delete large non-
coding genome intervals (gene deserts) from the mouse genome to determine the broad functional significance
of non-coding DNA beyond individual enhancer elements. (2) Working as Affiliates with the IGVF Consortium,
we will perform large-scale in vivo exploration of human variants with predicted impact on enhancer function to
assess human variation/mutation through our unique mouse engineering capabilities. This will include careful
validation and calibration of massively parallel reporter assays (MPRAs) and CRISPR screens through
comparison with in vivo mouse reporter assays. (3) We will continue to provide access to in vivo mouse assays
for the community and make our results available through the VISTA Enhancer Browser. In combination, in the
next phase of this program we expect to deliver impactful insights into the biology of enhancers as a major
category of non-coding genome function, apply innovative tools to demonstrate the in vivo impact of variants
identified by the IGVF consortium, and continue to make unique enhancer analysis tools and resources available
to the broader community.

Public health relevance
PROJECT NARRATIVE In addition to genes, human DNA contains hundreds of thousands of so-called enhancers, which represent switches that turn genes on and off in different cell types and tissues. While enhancers are important for normal human development, it is largely unknown how changes in human enhancer sequences impact on genome function and may contribute to human disease. We propose to use a suite of cutting-edge approaches to generate and examine large panels of enhancers with altered sequences and determine the consequences of these sequence changes for organism function.